Longitudinal Study of Transitions in Disability and Death among Older Persons

DESCRIPTION (provided by applicant): The overall objective of this proposal is to develop proper methods for characterizing aging-related changes in activities of daily living (ADLs) while accounting for differential survival patterns among older persons. The Yale Precipitating Events Project (PEP) is an ongoing longitudinal study of ADL disability, which has followed a large cohort of community-living older persons for over ten years. Monthly interviews and comprehensive assessments at eighteen-month intervals have been conducted to assess ADL disability, possible risk factors, potential intervening events, and deaths. PEP has documented relevant information that helps to elucidate the mechanisms underlying the occurrence and recovery of ADL disability and provided strong evidence that disability is a reversible and recurrent event with considerable heterogeneity and multiple potential pathways. However participants with greater disability tend to die earlier, hence the estimation of the extent of and overall burden of disability using available follow-up observations may be biased because the amount of ADL data varies according to participants'survival times. In current analytic methods for longitudinal study, death is typically dealt with in a similar fashion as dropout in non-aging research or treated as independent censoring, and often retrospective analysis is conducted conditioning on the proximity of death time. Most dropout models assume the existence of potential response after dropout, which does not apply to the aging-related functional change in older persons when death is the main reason for truncated measurements. Thus, a different analytic strategy is needed to deal with death in longitudinal aging research or any research in which death is an inevitable event. Our first aim is to depict the ADL ordinal response, which we view as manifested trajectory of underlying disabling process that is related to the risk process of death. Our second aim is to discover the distinct patterns representing the complex relationship between the disabling process and death. Our third aim is to study the dynamic transitions among the ADL states (i.e., (re)occurrence, worsening, improvement, and recovery of ADL disability) and death. In all the aims, the role of risk factors such as age, gender, cognitive impairment, physical activity level, depression, existence of acute or chronic comorbid conditions (e.g., stroke, hearing and sensory impairment) and physical frailty will be investigated. The findings from our proposal will provide aging researchers with an informative picture of aging-related ADL trajectories with varying survival patterns. The use of PEP data with monthly assessments addresses the previous concern that lack of frequent measurements that cover more than the period immediately before death has limited our understanding of the risk of death and biased the findings on ADL trajectories. The methods developed in this proposal are generally applicable to other longitudinal studies where death is a competing event, such as the longitudinal study of cognitive function in Veterans with Alzheimer's disease, study of the immune function in AIDS patients and study of quality of life in post-treatment cancer patients. PUBLIC HEALTH RELEVANCE: Disability in activities of daily living (ADL) in older persons incurs high cost in personal and long-term cares often leads to adverse health outcomes. Investigating patterns and factors associated with occurrence, deterioration, improvement and recovery of ADL and with death in older persons thus constitutes an important clinical and scientific task.

Public health relevance
Project Narrative: Disability in activities of daily living (ADL) in older persons incurs high cost in personal and long-term cares often leads to adverse health outcomes. Investigating patterns and factors associated with occurrence, deterioration, improvement and recovery of ADL and with death in older persons thus constitutes an important clinical and scientific task.